Local government expenditures as structural determinants of racial and ethnic disparities in firearm homicides

Project Summary/Abstract
Firearm violence exacts a devastating toll in the United States (US), with dramatically disproportionate impacts
on marginalized Black and Latiné communities. To date, public investments to address this issue
predominantly fund criminalization strategies with intensive policing and mass incarceration, but this has not
consistently or substantially reduced firearm homicide rates. A promising alternative approach focuses on
investing in meeting the essential needs of the communities that suffer from high levels of firearm violence, like
housing, youth programming, and a well-maintained built environment. While these interventions have
demonstrated success in reducing firearm violence, they have been limited to particular neighborhoods or
smaller geographic areas. Evaluations of investments to strengthen support services on a greater scale are
limited by a lack of availability of robust data. To fill that gap, this project will use public available local budgets
to build a detailed, longitudinal database of local funding expenditures for the carceral system and support
services for the 50 most populous cities from 2010-2022 (Aim 1a). The database will then be used to
categorize cities into groups based on their trajectories in the ratio of total support service funding to total
carceral funding per 100,000 residents, and explore city-level predictors of these groups (Aim 1b). In Aim 2, the
database will be used along with outcome and covariable data from the City Health Dashboard and various
public sources to estimate the changes in racial and ethnic disparities in firearm homicides associated with
increasing levels of funding allocations for (1) housing, (2) financial support, (3) family support, and (4)
community-focused public safety services; and decreasing funding levels for the carceral system. This
research is urgently needed as local policymakers are actively seeking evidence-based solutions to reduce
inequities in community violence. The research plan is complemented by an excellent interdisciplinary
mentorship team and training plan to develop strong foundations in the theoretical understanding of community
violence, practical knowledge of local budgetary processes, empirical knowledge of the effect of local funding
expenditures on health outcomes, advanced causal inference methods for longitudinal policy evaluation, and
communication skills for dissemination to diverse stakeholders. Building on the applicant’s background as a
surgical trainee entering the field of trauma surgery, the combined research and training plan will prepare the
applicant to successfully pursue a career augmenting clinical care of victims of violence with research to
facilitate structural interventions that prevent interpersonal violence from occurring in the first place. It will also
position him as a thought-leader and leader of empirical science on local funding as a structural determinant of
health.

Public health relevance
Project Narrative This project will build a granular, longitudinal database of local funding expenditures for the carceral system and community support services, thereby creating the ability to rigorously assess local budgets as structural determinants of health. The project will then use this novel database to assess the effect of local funding allocations on inequities in firearm violence, which disproportionately impacts segregated Black and Latiné communities. These findings can help inform local policymakers about modifying budgetary allocations as a strategy to address firearm violence.